Transcriptomics, pathobiology, and cardiac event in hypertrophic cardiomyopathy

PROJECT SUMMARY
Hypertrophic cardiomyopathy (HCM) is the most common genetic cardiac disease and causes
major adverse cardiovascular events (MACE) – e.g., arrhythmias, heart failure, and sudden
cardiac death. Invasive interventions to prevent MACE are available but can result in
complications. Current risk stratification strategy has limited power to predict which patient
would develop MACE and benefit most from preventive interventions. Furthermore, little is
known about the signaling pathways through which gene mutations mediate HCM pathobiology
and MACE. These major knowledge gaps have hindered efforts to prevent MACE in HCM. The
Harvard-Columbia Multi-center Hypertrophic Cardiomyopathy (HCM2) Biorepository is an
ongoing 3-center prospective cohort that enrolled 615 patients with HCM during 2014-2022. In
this large multi-center HCM biorepository, investigators have collected high-quality
biospecimens – i.e., 615 plasma and 120 left ventricular myocardium. Follow-up data include
biannual interviews, medical record reviews, and in-person exam every year, with >85% follow-
up to date (median follow-up, 3.1 years). The present R01 project will extend this large well-
characterized HCM biorepository by transcriptomically profiling both myocardium and plasma
samples in parallel, and by examining their relations to both HCM disease status and MACE. In
Aim 1, we will examine the association of signaling pathway dysregulation in the myocardium
with HCM disease status using qRT-PCR, single-transcript RNA-FISH, and RNA-Seq. In Aim 2,
we will specify signaling pathways and plasma circulating microRNAs that predict new-onset
MACE using transcriptomic profiling. Finally, using an unsupervised clustering-based approach,
Aim 3 will define HCM subtypes by integrating genetic, transcriptomic, proteomic, and clinical
data, and determine their associations with MACE. Our prior studies and preliminary work lend
compelling support to our hypotheses. The present R01 project will provide a unique opportunity
to reveal the molecular mechanisms of HCM pathobiology and progression to MACE through
examining signaling pathways by applying transcriptomic profiling to paired myocardium and
plasma. Moreover, the proposed study will also derive a novel risk stratification system in HCM,
which will allow us to precisely identify high-risk HCM subtypes that would benefit from
preventive interventions. The project will provide a strong evidence base for developing targeted
pharmacotherapies to prevent HCM pathogenesis and MACE through the modulation of specific
signaling pathways. The investigators have complementary and integrated expertise in all
relevant fields. The study matches well with the NHLBI strategic plan for HCM research.

Public health relevance
PROJECT NARRATIVE Hypertrophic cardiomyopathy is the most common genetic cardiac disease and causes a variety of major cardiovascular events such as arrhythmias, heart failure, stroke, and sudden cardiac death; however, effective pharmacotherapies to prevent disease manifestation or cardiovascular events are not available. In an ongoing, large multi-center cohort of patients with hypertrophic cardiomyopathy, the investigators will define the role of signaling pathway dysregulation in the disease pathobiology and the development of cardiovascular events by performing parallel transcriptomic profiling in both myocardium and plasma. This research has the potential to identify molecular targets for the prevention of disease manifestation and progression, and to offer novel approaches to specify high-risk subpopulations that benefit most from preventive interventions.